Mentoring investigators to improve health outcomes among persons with opioid and tobacco use disorder

ABSTRACT
Reductions in the health burden of tobacco and other substance use and of overdose mortality have not been
equitably distributed. A minority of persons with substance use disorder (SUD) access treatment. To improve
the equity in the delivery of evidence-based treatment of opioid-, tobacco- and other SUD, rigorous training is
needed to prepare the next generation of investigators in patient-oriented addictions research (POAR). I am a
general internist who has provided integrated primary care and opioid use disorder (OUD) treatment for over
16 years, co-direct fellowship programs to train general internists skills in SUD clinical care and research, and
lead a research program that aims to enhance tobacco treatment outcomes and delivery among persons with
co-occurring mental health and SUD. This Mid-Career Investigator Award will be used to support three
overarching career goals. First, this will formalize and expand my research mentoring activity to fellows and
early-career faculty focused on POAR. I will focus particularly on mentoring investigators from racial/ethnic
minority groups that are underrepresented in academic medicine and NIH-funded research. Second, I will
develop specific expertise in experimental and implementation science methods to enhance intervention
optimization and translation of clinical research findings to real-world application. The proposed research will
use a stakeholder-informed approach to develop and pilot test a flexible methadone treatment intervention.
This will both inform flexible, patient-centered, equitable care delivery in OUD treatment, and provide a
platform for research training for mentees in experimental and implementation science. Finally, I will develop
leadership skills in academic medicine to expand the research training infrastructure to promote equity and
diversity, and enhance research training in POAR. The proposed K24 application will leverage my strong
existing research program, an outstanding team of advisors, and robust institutional resources in research and
clinical care among persons with mental illness and SUD to support my career development and mentorship of
early-career investigators.

Public health relevance
PUBLIC HEALTH RELEVANCE Reducing the health burden of substance use disorders depends on rigorously training clinician scientists to conduct patient-oriented addictions research. This Mid-Career Investigator Award will support Dr. Nahvi to enhance her existing mentoring and leadership activities, and to translate findings from research trials to real- world settings. This mentoring and research plan will build research capacity to improve access to and outcomes of substance use disorder treatment.